Are Interventions Supporting Physical ACtivity modified by the Environment (InSPACE)?

Most youth and adults in the U.S. do not meet recommended levels of physical activity, despite the significant
and extensive physical and mental health benefits associated with being sufficiently active. It is critical to
population health to better understand the neighborhood built and social environment factors that influence
individuals’ access, capacity, and motivation to engage in positive health behaviors such as physical activity.
The parent grant (R01HL157166; Are Interventions Supporting Physical Activity Modified by the Environment?
or InSPACE) for this diversity supplement is attributing and pooling data from 50+ physical activity intervention
trials to examine whether the built and social environmental factors around individual participants’ home
influence their physical activity change during intervention. The proposed post-baccalaureate diversity
supplement adds the additional measures of gentrification to the existing InSPACE environmental measures in
order to 1) examine whether gentrification influences physical activity outcomes, and 2) whether gentrification
effects differentially impact those with marginalized racial/ethnic identities or are lower income. Gentrification,
the process of economic and other changes in historically disinvested neighborhoods, is occurring in many
U.S. cities. Understanding whether and how gentrification is related to individuals’ attempts to increase positive
health behaviors could strengthen the justification for investment in disadvantaged communities and inform
anti-displacement efforts. The diversity supplement candidate, Najma Abdi, recently graduated (June 2022)
from the University of Washington in Global Health. Ms. Abdi is focused on pursuing public health doctoral
training in health equity among immigrant populations and particularly interested in the impact of gentrification
and other environmental changes on population health. Ms. Abdi brings considerable qualitative research
experience from her undergraduate training and engagement in research. Through this diversity supplement,
Ms. Abdi will receive quantitative research training and mentoring that complement her qualitative research
training. Ms. Abdi will be mentored by the InSPACE investigator and research team in neighborhood
environment measurement, quantitative data processing, quantitative data analysis, and abstract and
manuscript development and submission. The combination of the content of the proposed research plan and
training in these quantitative research skills will facilitate the continuation of Ms. Abdi’s career on the path
toward being an action-oriented public health equity scientist.

Public health relevance
Increasing physical activity among individuals and the population is critical to improving health; neighborhood context and the environmental changes in neighborhoods may impact the likelihood of an individual increasing physical activity. Research is scarce on whether and how neighborhood gentrification, happening in many parts of the U.S., may influence individuals’ attempts to increase physical activity and particularly among those with marginalized identities. Supporting a post-baccalaureate researcher under-represented in science, this diversity supplement aims to understand potential gentrification effects on the efficacy of physical activity interventions, with the potential to inform neighborhood investment and anti-displacement efforts to address health disparities.